Neural Mechanisms of Predictive Impairments in Autism

Autism spectrum disorders (ASDs) are characterized by altered sensory processing and
intellectual disability. Atypical sensory processing has been recognized as an important diagnostic
criterion for autism and is predictive of social communication deficits later in life. ASDs are also
associated with impaired structural and functional connectivity within and between neocortical
areas. However, how impaired neural connectivity, which is present in ASDs, leads to impaired
sensory processing and learning is not understood. Recently, we have discovered new visual
familiarity-evoked theta oscillations in the primary visual cortex (V1). In Fmr1 KO mice, a mouse
model of Fragile X syndrome, these oscillations are weaker, shorter, and frequency shifted.
Furthermore, we have shown a similar emergence of visually cued theta oscillations in the anterior
cingulate cortex (ACC), an area connected to V1 and involved in social interaction, decision
making and error detection. We have also started mapping the neural circuit underlying these
oscillations. Our prior studies suggest that these familiarity-evoked theta oscillations and the
underlying changes in the neural circuit connectivity may be the cause of impairments in visual
learning and perception. Our preliminary data also suggest that Fmr1 KO mice demonstrate
impaired theta oscillations in a visual discrimination task. We have developed a computational
model to reproduce theta oscillations in the cortex. This proposal builds on foundational advances
by dissecting the mechanisms of theta oscillations in WT and Fmr1 KO mice. Using an integrated
approach combining mapping of neuronal connectivity in brain slices, in vivo extracellular
recordings, and behavior, we will: 1) map the circuitry necessary to form a theta oscillator in V1
and identify altered connectivity patterns within V1 and between V1 and ACC in Fmr1 KO mice,
2) examine how the strength of theta oscillations in V1 and ACC correlates with behavior in WT
and Fmr1 KO mice following learning, and 3) rescue theta oscillations by restoring FMRP
expression selectively only in the specific neuronal groups in Fmr1 KO mice guided by the
computational model. Based on our prior studies, preliminary data, and computational model, we
expect to see familiarity-evoked theta oscillations correlate with successful behavior in a visual
discrimination task. We also expect to identify the critical parts of the neural circuit required for
the generation of theta oscillations and its impairment in Fmr1 KO mice. Results from this proposal
will help inform the development of targeted neural circuit-based behavioral and pharmacological
therapeutics to enable personalized medicine for individuals with ASDs.

Public health relevance
Project Narrative The overall goal of this proposal is to determine, at the circuit and systems level, the role of visual familiarity- evoked oscillations in predictive behavior in wild type and Fmr1 KO mice, a model of Fragile X Syndrome. We will perform extracellular recordings with Neuropixels probes in V1 and ACC of awake mice, use optogenetics in combination with behavior to determine the relationship between oscillations and visual learning. We will map the underlying neural circuit responsible for these oscillations and impaired in Fmr1 KO mice.